ANCHR Research Core

PROJECT SUMMARY/ABSTRACT – Research Core
Understanding and addressing health issues among Alaska Native (AN) tribes necessitates community engaged health research based on careful study design, thoughtful analysis and interpretation, and proactive knowledge dissemination and use. The Research Core of the Alaska Native Center for Health Research (ANCHR) will leverage and coordinate institutional resources at the Alaska Native Tribal Health Consortium (ANTHC) to provide critical health research services to Research Project Leads (RPLs) and Center investigators who may lack the appropriate training, knowledge, or resources. The overarching goal of the ANCHR Research Core is to increase ANTHC health research capacity by building an efficient hub of research services to empower AN tribes to conduct health research. The Core will accomplish this goal through several specific aims. Specific Aim 1. Provide research design, biostatistics, bioethics, data acquisition and management, and knowledge dissemination services for ANCHR research projects. The Core will coordinate processes to oversee and deliver technical research support to RPLs. The Research Core will work with individual investigators to co-design research support plans with deliverables that meet the needs of each research project. Specific Aim 2. Promote, coordinate, and deliver the research services listed in Aim 1 to institutional researchers, Tribal Health Organizations in Alaska, and other IDeA institutions involved in health research. A Research Navigator employed by the Core will guide internal and external investigators through tribal research processes and ethics oversight and connect investigators to Core services and resources. The Research Core will prioritize research assistance to Tribal Health Organizations (THOs) in Alaska conducting health research given the mission of ANTHC to “optimize health and well-being through collaborative partnerships and services.” Research Core services will also be made available to health researchers at other IDeA institutions in Alaska and nationally. Specific Aim 3. Promote and advocate for community engaged research approaches that build on tribal knowledge, traditions, and strengths. The Research Core will promote best practices for community engaged and community based participatory research by strengthening collaborations with regional THOs, AN tribes, and experts in community engagement. The Core will provide community engagement support to RPLs, institutional researchers, and external researchers by leveraging internal and external resources as appropriate to the specific research project. The Core will connect investigators with research training program opportunities and aid in the dissemination of research results to tribal communities and other pertinent stakeholders.